Administrative Core

The Administrative core of UCI's Cancer Systems Biology Center, also to be known as the Center for
Complexity, Cooperation and Community in Cancer, will provide the administrative, communication and
oversight needs for the three projects and the shared resource and outreach/education cores. The Core will
establish an Executive Committee, which will be chaired by the Director, to be the primary governing body of
the Center. The Core will define, approve and review membership in the Center and provide logistical support
for Center members, including assisting investigators with meeting regulatory hurdles associated with research.
In addition, the Core will solicit, review and administer two types of pilot project grants: one directed at
graduate students and postdocs and the other directed at faculty. The Core will facilitate and guide
communication among Center members by the participation of Core key personnel in the research group
meetings of the projects and by organizing and participating in intra-Center workshops. The Core will guide the
integration of the Center into the Cancer Systems Biology Consortium by facilitating the sharing of Center
resources and member expertise across the Consortium, by participating in the Annual Consortium meeting
and by matching Center members with counterparts in the Consortium to foster new collaborations. The Core
will also organize annual site visits of NCI program staff. The Core will provide scientific and budgetary
oversight of the Center by soliciting and reviewing annual progress reports from the three projects, the two
cores, and the pilot project grants. The Core will appoint an External Advisory Board, which will provide annual
reviews of the Center as a whole. The Core will provide progress reports back to the NCI. Finally, the Core will
oversee strategic planning and the implementation of decision-making mechanisms for the scientific direction
and the budgeting of funds.

Public health relevance
Project Narrative Addressed in Overall component only, per RFA.